University of Rochester Mentoring Environment: Nurturing Training Opportunities in Research (UR-MENTOR)

The University of Rochester (UR) Medical Scientist Training Program (MSTP) provides support for predoctoral physician-scientist trainees in the UR School of Medicine and Dentistry (URSMD), as well as several programs in the School of Arts, Sciences and Engineering. With its breadth in training faculty, the MSTP will serve as the parent grant for this University of Rochester Mentoring Environment: Nurturing Training Opportunities in Research (UR-MENTOR) supplement. The objective of UR-MENTOR is to implement effective mentoring practices that nurture our mentors’ and trainees’ professional competency. UR-MENTOR includes a three- phase implementation strategy: Development (Phase 1), UR Dissemination (Phase 2), and Institutionalization (Phase 3). The implementation strategy will be guided by a carefully selected Oversight Committee, with collective expertise in programmatic leadership and evaluation, diversity initiatives, higher education, and mentorship development. We will offer structured mentoring mechanisms, including a combination of required and supplemental activities, which will be rooted in the innovative use of Self Determination Theory (SDT). As such, the proposed mechanisms will promote good mentoring practices that result in a culture of respect, leadership, equity, inclusion, and creativity. We will also utilize the resources offered through the UR Clinical Translational Science Insitutue (CTSI) and the National Research Mentoring Network (NRMN), including online toolkits and access to Facilitator Training through the Center for the Improvement of Mentored Experiences in Research (CIMER). UR-MENTOR will include assessment of core performance domains: Accessibility, Communication style, Critical thinking, Cultural awareness, Project management and leadership, and Teaching/Coaching. Using feedback from the assessment of these core performance domains, the UR- MENTOR Oversight Committee will build a Logic Model to identify the mentoring activities and outputs needed to achieve program outcomes. We will share the findings of our programmatic evaluation with both the UR community and a larger network, including the NIH, NRMN, and through scholarly publication. Importantly, the URSMD leadership is committed to our program and will create an Associate Dean of Mentor Development to sustain UR-MENTOR.

Public health relevance
The objective of this UR-MENTOR supplement is to implement a three-phase strategy that will culminate in effective mentoring practices and a sustained institutional commitment to mentor development. This will be achieved through rigorous training mechanisms, assessment, and evaluation and guided by a Logic Model to determine mentor training outcomes.